Improving the Integration of Mental Health and Substance Use Treatment into Ryan White-Funded Care Sites in Atlanta using an Implementation Science Approach

PROJECT SUMMARY/ABSTRACT
In response to RFA-MH-20-521, this R34 application proposes to adapt a stigma-reduction training, develop a
new prescribing platform, and pilot test these implementation strategies to improve the integration of
pharmacotherapy for serious mental health disorders and alcohol use disorder (AUD) in Ryan White care sites in
three counties of the Ending the Epidemic Plan—Dekalb, Gwinnett, and Cobb Counties in the Atlanta Metro area.
We propose to engage a Community Collaborative Board (CCB) that includes people living with HIV (PLHIV) and
conduct in-depth interviews with PLHIV to adapt the Health Policy Project's stigma-reduction training to address
mental health and substance abuse-related stigma. We also will engage an expert panel of psychiatrists and
experts in HIV medicine and conduct focus group discussions with providers to inform the development of the
You℞ Decision prescribing platform, which will help providers make decisions about prescribing medications for
depression, PTSD, bipolar disorder, and AUD among PLHIV. This platform will be accessible via mobile devices—
smartphones and tablets—and will use algorithms based on best practices in HIV primary care and refined based
on feedback from experts in HIV medicine and psychiatry to guide HIV providers in developing the best
medication regimens for patients with comorbid disorders. For this planning grant, we will use the Consolidated
Framework for Implementation Research, the ERIC recommendations, and Proctor's implementation taxonomy to
explore the determinants of implementation, identify implementation strategies, and assess the acceptability of the
stigma-reduction training and assess feasibility and acceptability of the You℞ Decision prescribing platform in
Positive Impact Health Centers, which are Ryan White-funded care sites. We will also conduct a pilot trial to
assess the preliminary impact of the stigma-reduction training to reduce clinic-level stigma and the You℞ Decision
prescribing platform to increase providers' self-efficacy related to prescribing psychiatric medication and
naltrexone (targeted mechanisms) and their provision of pharmacotherapy for depression, PTSD, bipolar disorder,
and AUD (adoption). Specific Aims: Aim 1: To conduct formative activities with PLHIV, HIV care providers,
and our CCB to adapt a stigma-reduction training to address mental health and substance abuse-related
stigma among clinic staff and engage HIV care providers and an expert panel to develop the You℞ Decision
prescribing platform to support HIV care providers to offer pharmacotherapy to treat depression, PTSD,
bipolar disorder, and AUD. Aim 2: To assess the acceptability of the stigma-reduction training among clinic
staff and the feasibility, acceptability, and adoption of using the You℞ Decision prescribing platform during
clinical encounters among providers in HIV care settings. Aim 3: To use idiographic methods to conduct a
pilot trial to assess the preliminary impact of the stigma-reduction training on clinic-level stigma and of the
You℞ Decision prescribing platform on HIV care providers' self-efficacy to prescribe psychiatric medications
and naltrexone as well as the impact of the stigma-reduction training and platform to increase the percentage
of eligible patients who receive prescriptions to treat depression, PTSD, bipolar disorder, and AUD.

Public health relevance
PROJECT NARRATIVE Many people living with HIV (PLHIV) have comorbidities (more than one chronic condition) such as depression, PTSD, bipolar disorder, and/or alcohol use disorder (AUD) that are not being treated, which increases the likelihood that they will not be retained in HIV care. Many Ryan White-funded care sites do not have the resources to pharmacologically treat PLHIV with comorbid mental health disorders and/or AUD. Additionally, stigma may contribute to the lack of treatment among PLHIV with comorbidities. This small planning proposal with Ryan White and community partners proposes to adapt a stigma-reduction training to reduce clinic-level stigma; develop a prescribing platform to help providers' clinical decision-making regarding pharmacotherapy for mental health disorders and/or AUD; and test the feasibility to improve the integration of psychiatric medication and naltrexone into Ryan White-funded care sites in the Atlanta area. The study findings may offer the impetus for additional studies or funding to scale up these strategies to Ryan White-funded care sites in Georgia.